Improvement of whole genome sequencing capacity for outbreak investigation of foodborne pathogens for FDA VET-LIRN

FDA CVM Vet-LIRN PROGRAM GRANT PROPOSAL FOR FOA # PAR-18-604 ABSTRACT This grant proposal from the Ohio Department of Agriculture (ODA) is in response to Funding Opportunity Announcement (FOA) # PAR-18-604 from the Food and Drug Administration’s (FDA) Center for Veterinary Medicine (CVM) Office of Research Veterinary Laboratory Investigation and Response Network (Vet-LIRN). The purpose of this proposal from ODA’s Animal Disease Diagnostic Laboratory (ADDL) is to address the following key project areas: 1. Procurement of supplies needed for WGS testing efforts or method improvement. 2. Purchase of equipment needed to conduct diagnostic testing for Vet- LIRN case investigations. This grant proposal also addresses the CVM request for sample analysis commitment as well as the laboratory’s ability and willingness to complete the proposed research in a timely manner. Several additional documents including the internal Proficiency Testing (PT) results (see Research Stragety), and certificate of AAVLD accreditation (appendix of Research Plan) are provided along with the

Public health relevance
FDA CVM Vet-LIRN PROGRAM GRANT PROPOSAL FOR FOA # PAR-18-604 NARRATIVE This Vet-LIRN capacity building project strengthens the capacity, collaboration, and integration of food-safety laboratories and networks, thereby facilitating an effective and coordinated response to future human and animal food safety issues. Identifying new and rapid analytical techniques and providing well-equipped and staffed laboratory facilities increases the effectiveness of Federal, State, and local partnerships to coordinate food safety and defense resources and reduce the incidence of foodborne illness. This project will support the identification and adoption of emerging technologies and the harmonization of analytical methods used by new equipment platforms.